Markerless Tracking of 3D Posture to Reveal the Sensory Origins of Body Schema

The goal of this proposed research is to reveal the sensory origins underlying the body schema
representation. Body schema is the brain's internal model of the body's spatial configuration. This internal
representation is critical for sensorimotor processing, movement control, and self-awareness, and is
continuously updated during movement. Body schema representations are disrupted when somatosensory input
is lost. The first step toward discover the neural correlates of body schema is to uncover neural mechanisms that
generate body posture representation. We hypothesize that sensory inputs from primary somatosensory cortex
(S1) and secondary somatosensory cortex (S2) to the posterior parietal cortex (PPC) are transformed to
construct a body posture representation.
To delineate the mechanisms underlying the neural coding of body posture, this project will utilize large-
scale monitoring, apply interventional tools, develop new data analysis tools, and integrate new approaches. Our
approach is to perform large-scale electrophysiological recording and novel markerless tracking of 3D posture
in freely moving mice. To track posture, the first aim is to adapt a markerless tracking pipeline comprised of a
deep 3D convolutional neural network to process high-speed videography of mouse behavior from multiple
cameras. The second aim is to perform large-scale recording of neurons in S1, S2, and PPC and use advanced
computational approaches to determine which postural features best explain the activity of neurons in these
cortical areas. Finally, the third aim is to use optogenetic and projection-specific manipulations to address the
causal impact of proprioceptive inputs from S1 and S2 on coding of posture in PPC. This research promises to
uncover how sensory inputs are involved in generating the body schema representation and guiding behavior.
Extensive training will be required to carry out this project and achieve my goal of earning a tenure-track
professor position. The rigorous methodological and intellectual environment in Dr. Fan Wang’s lab and the Duke
Neurobiology community will advance my conceptual knowledge and technical skills. I will implement deep
learning techniques through training and collaboration with specialists. I will learn new techniques by attending
Neuropixel and computational neuroscience courses. Finally, I will develop my professional skills by frequent
attendance of seminars, workshops, and meeting with a postdoctoral mentorship committee.
The proposed project will be conducted in the Department of Neurobiology at the Duke University Medical
Campus. This interdisciplinary community at Duke will bolster the research and training included in this
application through frequent interaction with talented and collaborative faculty, organization of seminars and
symposia, numerous opportunities to practice research talks and receive valuable feedback, formation of a
personalized postdoctoral mentorship committee, extensive career and professional training, and invaluable
support from the postdoctoral association.

Public health relevance
Project Narrative Body schema, the brain’s internal model of the spatial configuration of its body parts, is normally updated during movement, but can be disrupted following amputation, stroke, or deafferentation. Understanding how neural circuits generate body schema representation in health and disease could pave the way for improvements in surgical practice, stroke recovery therapy, brain-machine interface technology, and prosthetic limb engineering. Furthermore, sustaining an internal model of the body is a key element of awareness of one’s own body and the body of others, so findings on the sensory origins underlying body schema will have implications ranging from sensorimotor processing, motor control, interpersonal representations, and social cognition.